Mayo Clinic Center for Clinical and Translational Science (CCaTS)

The long-term objective of the TL1 Program within Mayo Clinic CCaTS is to train tomorrow’s workforce of team-based, translational biomedical researchers at predoctoral levels using the R4 approach to learning (the Right content for the Right learner at the Right time using the Right educational modality). This will create a new generation of researchers who will lead multidisciplinary teams across the translational spectrum to improve health for all communities. The TL1 Program has 3 Specific Aims: 1) Transform the preparation of trainees for success in the workforce of the future, including uncovering the hidden curriculum for research and further developing our supportive scholar community in partnership with the KL2 Program. 2) Expand and integrate training opportunities in translational science, including foci in patient and community engagement and data immersion to promote health for all people, using novel approaches including rotations in community engagement and data immersion; new curricula in artificial intelligence, bioinformatics, and clinical trials; and newly required curricula. 3) Launch trainees toward a successful translational science career of their choice by providing opportunities to learn about a variety of career opportunities and to develop a network that can provide immersive experiential learning with shadowing and externships within community-engaged research, industry, regulatory agencies, start-ups, and organizations that succeed through teamwork. We will rigorously evaluate outcomes and disseminate successful models, so that these novel programs can be continuously improved and the CTSA Consortium and others can benefit from these experiences.
Although our overall predoctoral program includes several degree and pathway programs, this application focuses on the PhD Program in Clinical and Translational Science, an innovative PhD track developed de novo to train leaders of translational research teams within an extensive and successful framework. We will build upon our considerable experience, retaining those elements of proven benefit and introducing new elements. Enhancements to the Program include expanded training opportunities; expanded opportunities for experiential learning on the Mayo Clinic campus and in partner institutions and novel extramural environments; enhanced ability to tailor the didactic curriculum to individual needs; and leveraging institutional and programmatic strengths to help individual trainees develop a career trajectory in translational science. We will increase our established collaboration with partner CTSA institutions at the University of Minnesota and in the Upper Midwest Consortium and further develop rigorous evaluation systems to track individual and Program outcomes using innovative and comprehensive metrics. We will disseminate successful practices through CTSA networks and national leadership.

Public health relevance
The Mayo Clinic Center for Clinical and Translational Sciences (CCaTS) accelerates innovations in clinical research and partners with our stakeholders and communities to improve patient care and human health for all people. It supports scientists who bring new discoveries to clinical practice, trains a multidisciplinary workforce prepared to address the urgent health care needs of all communities in a rapidly changing environment and works closely with other research centers across the country to share innovative approaches.